Project 3: CRISPR Genome Editing to Understand and Correct STAT3 GOF Immune Dysregulation

Project Summary/Abstract
Signal transducer and activator of transcription 3 (STAT3) gain of function (GOF) germline mutations are
a monogenic cause of a syndrome of early-onset multiorgan autoimmune and lymphoproliferative disease for
which the only current definitive cure is an allogeneic hematopoietic stem cell transplant. Despite the clear
genetic understanding of this syndrome, mechanistic cellular and molecular understanding of this syndrome
remains obscure, particularly with regards to the STAT3 GOF effects on T cells, the cell type thought to be
responsible for much of the autoimmunity seen in STAT3 GOF patients. This proposal is part of a Program
Project Grant that seeks to gain mechanistic insight into the immunological etiology of this disease incorporating
human patient samples, mechanistic mouse studies, T cell culture experiments, and functional genomics
approaches. This specific Project within the Program Grant seeks to leverage functional genomics approaches
powered by CRISPR-Cas9 technology to understand how STAT3 GOF variants affect T cell function. CRISPR-
Cas9 genome engineering technology is driving a revolution in modern biology. Scientists now possess
unprecedented capabilities to test the cellular functions of human genetic sequences and correct mutations that
cause disease directly in primary mouse and human cells. Of relevance to this Project proposal, our lab has
pioneered methods and systems to conduct targeted and genome-wide knockout screens in primary T cells from
mice and humans. Further, we have developed an efficient method for orthogonal validations using Cas9:single-
guide RNA ribonucleoprotein (Cas9 RNP) electroporation coupled with multiplexed flow cytometric phenotyping.
These advances now position us to use functional genomics approaches in mouse and human T cells to reveal
novel pathways that control abnormal T cell function in STAT3 GOF syndrome, prioritize novel targets in further
studies for drug development, and improve the design of genetically reprogrammed cell-based therapies.
Specifically, Project 3 seeks to implement unbiased CRISPR functional genetic approaches in mouse T cells
modeling STAT3 GOF mutations to identify critical gene targets that modulate STAT3-mediated inflammation
(Aim 1a, 1b). Further, we seek to leverage the information from these screens to improve function in human
patient T cells (Aim 1c). Finally, Project 3 seeks to use cutting-edge non-viral CRISPR based methods to correct
STAT3 GOF mutations in actual patient T cells, as well as to develop a preclinical approach to replace selected
STAT3 exons in primary human hematopoietic stem progenitor cells (HSPCs) (Aim 2). Taken together, these
studies will form the basis for a framework to understand how STAT3 GOF variants alter T cell function to drive
inflammatory disease as well as open multiple avenues towards immune cell CRISPR gene targeting to treat
autoimmunity.